Commercialization of methods and reagents for high-throughput single cell analysis

PROJECT SUMMARY / ABSTRACT
Single-cell RNA sequencing (scRNAseq) provides unprecedented insight into the gene regulatory pathways of
living cells in complex tissues. Fluent BioSciences has developed Pretemplated Instant Partitioning for
single-cell RNA sequencing (PIPseq) that eliminates the cost and complexity of bespoke microfluidics and
instrumentation and features a simple, flexible workflow that can be implemented in any laboratory setting.
With Phase I SBIR support (1 R43 GM137648-01A1) we have demonstrated that PIPseq is intrinsically
scalable and is capable of capturing from hundreds to millions of cells in a single reaction. The advent of new,
high capacity, and low cost sequencing modalities such as that developed by Ultima Genomics makes high
cell-input single cell transcriptomics not only feasible but practical, enabling previously inaccessible
experimental modalities. In this proposal, we will expand the capabilities of PIPseq single cell analysis to
provide simple, scalable, and cost-effective solutions for high cell input applications including deep tissue
profiling, multiplexed drug testing, and pooled CRISPR screening.

Public health relevance
PROJECT NARRATIVE Fluent BioSciences has demonstrated that Pretemplated Instant Partitioning for single-cell RNA sequencing (PIPseq) can provide simple, flexible, and inexpensive solutions for single cell analysis at up to million-cell scale. We will develop specific PIPseq applications that combine PIPseq sample preparation with emerging sequencing technology from Ultima Genomics to provide enabling solutions for PIPseq in deep tissue profiling, multiplexed drug testing, and pooled CRISPR screening.